Admin-Oversight

The National Center for Simulation in Rehabilitation Research (NCSRR) is organized to enable the medical rehabilitation research community to optimally benefit from OpenSim, an advanced software system that allows researchers to create patient-specific dynamic simulations of movement. Our director, Dr. Scott Delp, has a decade’s worth of experience successfully running NIH National Centers. Dr. Delp will lead the professional staff, external advisors, collaborators, awardees, and interactions with NIH staff to achieve the following specific aims: 1. Implement an effective administrative plan to manage the Center’s diverse activities. 2. Communicate with and integrate input from our Scientific Advisory Board, our consultants, and NIH staff. 3. Manage the selection and progress of pilot projects and visiting scholars. 4. Set goals and assess the Center’s progress towards achieving these goals. 5. Evaluate the quality and utility of the Center’s programs. 6. Create and maintain a vibrant, sustainable community of experts in rehabilitation research and modeling and simulation. 7. Promote the Center’s resources and activities. 8. Collaborate with other medical rehabilitation research centers funded under this FOA. Excellent administration and management teams will be essential for coordinating the many diverse activities of the NCSRR. The extensive and diverse experience of our leadership team, and our track record of administrative successes, will ensure the success of the interdisciplinary NCSRR.